The direct transcriptional regulation of cell cycle genes by cell identity factors during myeloid differentiation

Summary
During blood development, most stem cells are quiescent, enter the cell cycle infrequently to amplify as short-term
hematopoietic stem cells and lineage-restricted progenitors and then exit the cell cycle in order to permanently
differentiate into mature and functional cell types. Cell cycle exit is relevant to cancer since leukemic stem cells
(LSCs) undergo a similar process of expansion and exit during tumorigenesis. This project seeks to uncover
the mechanisms by which cell cycle exit is achieved during terminal myeloid differentiation. While transcription
factors (TFs) that specify myeloid cell identity, PU.1 and C/EBPα/β/δ, are known to inhibit the cell cycle, whether
they directly regulate the expression of canonical cell cycle genes acting at the G1/S transition is not known.
This project will investigate the hypothesis that PU.1 and C/EBP-family TFs bind to distal enhancers of cyclin-
dependent kinase (CDK) inhibitors (CDKIs) and Cyclin D2 to upregulate or downregulate them respectively in a
cell-identity speciﬁc manner. Aim 1 will test whether the identiﬁed CDKIs and Ccnd2 cause cell cycle exit in an
in vitro model of myeloid differentiation. Gain of function experiments for the CDKIs Cdkn1a, Cdkn1b, Cdkn2c,
and Cdkn2d and loss of function experiments for Ccnd2 will be performed and the proportion of cells exiting the
cell cycle will be measured. How genome-wide gene expression and DNA accessibility changes with cell cycle
will be determined by synchronizing cells and performing RNA-Seq and ATAC-Seq time course experiments.
Cells that have exited during differentiation will be isolated using dye dilution techniques and their transcriptome
and DNA accessibility will be compared to those of cycling cells to uncover new candidates for mediating cell
cycle exit. Aim 2 is to determine how cell cycle genes are regulated by PU.1- and C/EBP-bound enhancers
at the resolution of TF binding sites. A set of enhancers of the CDKIs and Ccnd2 has been identiﬁed using
high-resolution DNA accessibility proﬁling (ATAC-Seq). The occupancy of PU.1 and C/EBP-family TFs at their
binding-sites in these enhancers will be conﬁrmed using CUT&RUN. Putative enhancers will be tested using
reporter genes integrated in a site-speciﬁc manner with CRISPR/Cas9 into the ROSA26 locus. Predicted binding
sites will be validated using site-directed mutagenesis of the reporter locus. Whether PU.1 and/or C/EBP-family
TFs binding to the candidate enhancers regulate their endogenous targets and cell cycle exit will be checked by
mutating the validated binding sites in the endogenous locus with CRISPR/Cas9 homology directed repair (HDR).

Public health relevance
Narrative Proper control of cell division is crucial for the replenishment of hundreds of billions of blood cells on a daily basis. Mutations that disrupt the genetic machinery regulating cell division can cause cancer. This project would advance our understanding of the genetic machinery that stops cell division during the maturation of white blood cells.